Early Detection and Monitoring of Osteonecrosis of the Femoral Head

PROJECT SUMMARY: Osteonecrosis of the femoral head [ONFH] is a crippling hip disorder affecting children
and young adults that can lead to collapse of the femoral head, osteoarthritis, and the need for a hip
replacement at a young age. Clinical management of young patients with early-stage ONFH focuses on
preventing femoral head collapse, at which point little can be done to salvage the hip joint. However, one of the
primary hip preservation treatments for early-stage ONFH, core decompression surgery (which involves drilling
into the femoral head), fails to prevent disease progression in 30% or more of patients. This failure can be
attributed in part to delayed diagnosis and limited ability to predict and monitor treatment response using
current clinical imaging methods (radiography and conventional T1- and T2-weighted magnetic resonance
imaging [MRI]). Our long-term goal is to improve clinical outcomes for children and adults with or at risk for
ONFH through the synergistic advancement of imaging and therapies. The objective of this R01 proposal is to
address the need for better imaging to inform treatment of early-stage ONFH by characterizing the sensitivity
of advanced MRI techniques to assess bone ischemia, necrosis, and repair. Our central hypothesis is that
quantitative MRI methods are sensitive in detecting early-stage ONFH and provide quantitative measures of
the degree of ischemic injury and subsequent repair to the femoral head. We will build upon our promising
work using a piglet model of ischemic ONFH, which has demonstrated that quantitative, non-contrast-
enhanced MRI techniques, including relaxation time mapping, diffusion imaging, and perfusion imaging, are
sensitive and reliable in detecting ischemic injury to the femoral head. In Aim 1, we will expand upon our piglet
model studies to identify the cellular changes driving the sensitivity of the quantitative MRI methods to ischemic
injury and drilling-induced repair of the femoral head. Animals will be imaged in vivo at 3T MRI, and the femoral
heads will subsequently be assessed histologically. In Aims 2 and 3, we will take initial steps to clinically
translate the quantitative MRI methods by conducting pilot studies to detect early-stage injury and monitor
response to core decompression treatment in patients with ONFH. In Aim 2, we will evaluate whether the
quantitative MRI methods can detect femoral head ischemia without use of a gadolinium contrast agent in a
pilot study of children with juvenile idiopathic ONFH (also known as Legg-Calvé-Perthes disease). In Aim 3, we
will evaluate whether the quantitative MRI methods can detect a reparative response to core decompression in
a pilot study of adults being treated for early-stage ONFH, and whether the response differs in those patients
whose treatment fails to prevent femoral head collapse versus those whose treatment is successful in
preventing disease progression. Collectively, these aims are a critical step toward improving long-term
outcomes for young patients with early-stage ONFH through advancement of imaging to allow for new
opportunities for therapeutic intervention and the evaluation of the efficacy of new treatments.

Public health relevance
PROJECT NARRATIVE: Osteonecrosis of the femoral head (ONFH) is a major cause of hip osteoarthritis and subsequent total joint replacement. Our research aims to improve clinical management and treatment of ONFH, and thereby reduce the overall burden of osteoarthritis, by advancing medical imaging techniques to enable earlier diagnosis of the disease and better prediction of clinical outcome to inform treatment decisions.